Bicoastal Marmoset Breeding Center

Project Summary
The common marmoset (Callithrix jacchus) has experienced unprecedented growth in research across the
United States and is rapidly emerging as a likely keystone biomedical model system in the next chapter of
scientific discovery. Over the past decade, the number of marmoset laboratories in the US has quadrupled.
There are now over 40 Principal Investigators who use marmoset as the model system in their research.
Neuroscience is the primary engine driving marmoset research today, as nearly three quarters of marmoset
researchers in the US use this model species to examine molecular, systems or cognitive functions in normal
and diseased brains. Although these grassroots have been successfully forged new paths of scientific inquiry
using marmosets in the U.S., critical bottlenecks have emerged that threaten to thwart the continued growth of
this emerging model system. We propose to establish a Bicoastal Marmoset Breeding center, with two
breeding colonies, one on the East Coast at Johns Hopkins University (JHU) and the other on the West Coast
at University of California at San Diego (UCSD). The Center aims to produce a large number of marmosets to
supply the marmoset research community in the U.S. Because of the non-availability of air transport of NHP in
U.S. and prohibitively expensive ground transportation of NHP between the east and west coast, these two
breeding colonies are strategically located to support the marmoset community in regions near each colony.
We believe such a center is needed to address the national shortage of marmosets in order for the marmoset
model to realize its full potential as a keystone species in the next chapter of neuroscience that serves to
accelerate the rate of discovery and better understand human neurological disease.

Public health relevance
Public Health Relevance Statement: A proper model system is crucial to advance the studies of human neuropsychiatric diseases. The proposed project will contribute to the research in this field by making critical resource available to neuroscience research community.